Research Informatics Shared Resource

The Rl Shared Resource provides informafics support for laboratory, clinical, translafional, and population sciences research in the following areas: • Database design, development, installafion, and support • Software applicafion and design, development, installafion, and support • Bioinformafics algorithm design and development • Software applicafion server administrafion • Web development for user interfaces The Rl Shared Resource, led by Samir Courdy, Resource Director, is comprised of a staff of 12 software engineers and database administrators with extensive computer science and medical informatics background. The team has developed many different software systems involving clinical research, biospecimen tracking, high-throughput data management and annotation, and genomics data with enhanced analysis capabilifies. The projects are prioritized by a Faculty Advisory Committee, HCI Senior Directors, and CCSG Program Leaders. As a support core, the Rl Shared Resource does not operate as a recharge center. The majority of effort supports other CCSG Shared Resources or peer-reviewed research projects. Support comes from HCI institufional funds, the CCSG grant, and from research grants requiring extensive software development.